Northern New England Clinical and Translational Research Network - N3C Initiative

ABSTRACT
The National Covid Cohort Collaborative (N3C), created by the National Center for Advancing
Translational Sciences (NCATS) and the National Center for Data to Health (Cd2H) have
created a centralized national database and analytic platform for scientists to use to study
COVID-19 and identify potential treatments. It is a partnership among 75 institutions that is
funded by the National Institutes of Health. Collaborators have contributed data so far on nearly
6 million COVID-19 positive patients, as well as several million control patients who tested
negative for COVID-19. The collaborators use the clinical data on these patients to answer
critical research questions to address the pandemic and accelerate development of effective
treatments. The Northern New England Clinical and Translational Research Network has
actively participated in N3C for over 2 years and is submitting this administrative supplement to
allow for our continued participation for another year. This application details our past
accomplishments and describes our planned work for the coming year.

Public health relevance
NARRATIVE COVID-19 has emerged as a major critical health threat to our population. The N3C data registry is an important resource for researchers who are studying COVID-19 effects and treatments. This registry will ultimately contribute to better management and treatment of COVID-19.